Cancer Genomics Technologies

The TCI Cancer Genomics Technologies Shared Resource (CGTSR) facilitates scientific, translational, and clinical breakthroughs by harnessing cutting-edge molecular -omics techniques, advanced instrumentation, and computational methods. The CGTSR offers TCI members the latest developments in bulk, single-cell, spatial, and in-situ multi-omics data generation platforms; while also providing expertise to optimize experimental design, data quality, affordability, and access. The team is comprised of 29 staff and faculty harbored in the brand new Mount Sinai Discovery and Innovation Center which includes instrumentation, molecular and cell biology spaces, and BSL2/BSL2+ laboratories. Post-sequencing data analyses are performed using the secured and centralized Mount Sinai High-Performance Computing facility with 1.5 Petabyte storage capacity. The CGTSR maintains a comprehensive suite of genomics services that accelerates cancer discovery, inter- and intra-programmatic collaborations within the TCI community, and benchmarks new technologies to continually match the evolving needs of TCI members. The Specific Aims of this Shared Resource are to: (1) Provide comprehensive Next Generation Sequencing (NGS) equipment, services, and expertise; (2) Offer comprehensive single cell, low abundance, and spatial transcriptomics equipment, expertise, and services.